IL1beta signaling in SMCpromotes beneficial changes in late stage atherosclerotic lesion pathogenesis

Atherothrombosis, resulting from rupture or erosion of unstable atherosclerotic plaques, is the leading cause of
death worldwide. However, the mechanisms that regulate the stability of late stage atherosclerotic lesions remain
poorly understood. The dogma is that: 1) plaques containing a large necrotic core, a thin fibrous cap, and large
numbers of CD68+ cells relative to Acta2+ cells [presumed to be macrophages (MФ) and smooth muscle cells
(SMC) respectively] are more prone to rupture; and 2) SMC play a beneficial role because they are the primary
cell type responsible for formation of a matrix-rich protective fibrous cap. However, recent studies by our lab
involving simultaneous SMC lineage tracing and SMC-specific knockout (KO) of the stem cell pluripotency genes
Oct4 or Klf4, provide compelling evidence challenging this dogma including showing that SMC can have major
beneficial or detrimental effects on late stage lesion pathogenesis depending on the nature of their phenotypic
transitions. As such, we sought to identify mechanisms to promote beneficial (atheroprotective) SMC phenotypic
transitions, and hypothesized that treatment with an anti-IL1β antibody (Ab) to globally suppress inflammation
would induce such changes. However, completely contrary to expectations, treatment of our SMC lineage-tracing
ApoE-/- mice with the anti-IL1β Ab between 18-26 weeks of Western diet resulted in multiple detrimental changes
including a marked reduction in fibrous cap thickness and collagen content, rapid loss of fibrous cap SMC and
replacement with MФs, and impaired outward remodeling. Studies in this proposal will test the hypothesis that
that IL1β signaling in SMC plays a critical beneficial role in late stage lesion pathogenesis including being
required for formation and maintenance of a protective fibrous cap. Aim 1 will determine if persistent IL1R1
signaling within SMC is required for maintenance of a SMC rich fibrous cap. Studies will include determining the
contributions of each of the IL1R1 ligands IL1β, and IL1α, as well as IL1Ra. We will also determine if SMC-
specific tamoxifen conditional KO of the IL1R1 receptor, after establishment of advanced atherosclerosis by 16-
18 weeks of WD feeding, results in loss of SMC fibrous cap coverage and other detrimental changes consistent
with plaque destabilization. Finally, we will determine if IL1β dependent phenotypic changes of SMC observed
in our mouse studies occur in human lesions and if these changes are predictive of plaque rupture or erosion.
Aim 2 will define critical variables and mechanisms that influence the effects of IL1β neutralization on late stage
lesion pathogenesis including those that may help to reconcile our findings with the recent positive outcomes of
the CANTOS Clinical Trial. This will include testing the hypotheses that the response to anti-IL1β therapy is
highly dependent on whether there is persistent hyperlipidemia/unresolved inflammation, and/or concurrent
myocardial infarction/heart failure. Taken together, the proposed studies will provide key insights regarding
fundamental mechanisms that regulate late stage lesion pathogenesis, and may contribute to development of
improved therapies for treating patients with advanced atherosclerosis.

Public health relevance
Project Narrative/Relevance: Atherosclerosis is a progressive chronic inflammatory disease that remains the leading cause of death in the USA and worldwide in spite of widespread use of statins, other lipid lowering strategies, and life-style modifications. As such, there is an urgent need for more effective therapies. Among the most popular of these are those that globally inhibit inflammation. However, it is important to remember that inflammation evolved as a protective process that is essential for our resistance to disease pathogens and for healing of damaged tissues. The studies in our grant application will determine mechanisms by which treatment with an anti-inflammatory IL1β neutralizing antibody influences late stage atherosclerotic plaque pathogenesis, including identifying key parameters that determine if this therapeutic approach is not only effective in reducing cardiovascular disease risk but is also safe. Whereas excessive inflammation clearly exacerbates lesion pathogenesis, we postulate that excessive global inhibition of inflammation, or treatment of the wrong patient cohort, may have catastrophic detrimental consequences and hurt rather than help the patient.